Core B

PROJECT SUMMARY
The Exosome isolation and characterization Core (Core B) will provide the critical basis for the
proposed projects by generating exosomes and carrying out their characterization together with
content analysis for all scientific projects. The core will offer integrated services for exosome
production and assessment of exosome contents from different cell supernatants and mouse and
human plasma samples. Accordingly, Core B will maintain equipment and provide staffing to offer
Projects the following services: 1) Exosome isolation and characterization, and 2) Assessment of
exosome contents by molecular approaches and bioinformatics support. The Core is centrally
located in the Center for Translational Medicine, medical education research building which also
houses the cardiovascular research center and administrative offices. The Exosome core is
composed of fully equipped exosome production and molecular analysis units. PPG investigators
will be able to equitably utilize Core resources with the core designed specifically to serve this
multi-project PPG. Accordingly, it will maximize quality control and enhance collaborations
between projects, thus enhancing the synergy of this integrated research program.

Public health relevance
PROJECT NARRATIVE Exosome are tiny vesicles secreted by most cardiac cells and are key mediators of cell to cell communication by transferring donor cell molecular cargo to recipient cells. Exosome are loaded with proteins, mRNAs and microRNAs that are specific to the parent cells and regulate molecular processes once delivered to target cell types. Therefore this core is essential for isolation, characterization, and analysis of exosome contents from different sources that will be utilized by all three scientific projects.